Cooperative Agreement to Support the Joint Institute for Food Safety and Applied Nutrition (JIFSAN)

Project Summary/Abstract
The Joint Institute for Food Safety & Applied Nutrition (JIFSAN) at the University of
Maryland, College Park was established by the University and the U.S. Food & Drug
Administration (FDA) in 1996 to advance sound strategies that improve public health,
food safety, and applied nutrition using risk analysis principles through cooperative
research, education and outreach programs. JIFSAN programs support the Food Safety
Modernization Act that emphasizes the concept of preventing food safety-related
problems before they occur and enhance FDA's efforts to partner with other nations to
improve U.S. and worldwide health. JIFSAN's vision is to be an internationally
recognized source of scientific information and trainings on food safety, applied nutrition
and animal health. This renewal is to obtain funding for an additional five years (26-30)
of the FDA Cooperative Agreement. This proposal includes administrative, research
and programmatic support to 1) establish multi-institutional, multidisciplinary applied
research projects to address complex food/feed safety and public health issues
associated with products that FDA regulates; 2) continue the development of
mechanisms for the exchange of technical information and scientific concepts between
FDA and other sectors of the international and domestic community; 3) continue the
development and refinement of programs based on the application of the principles of
risk analysis to address food/feed defense and safety issues; and 4) continue
developing innovative education and outreach programs that will provide opportunities
to leverage resources among various sectors of stakeholders to address complex safety
issues associated with an increasingly diverse global food/feed supply.

Public health relevance
Project Narrative As one of four Centers of Excellence (COEs) of FDA's Center for Food Safety and Applied Nutrition, JIFSAN conducts various research and outreach activities in food safety and applied nutrition to help ensure that regulatory decisions have a sound science footing and that the best methods and tools are available to advance food and public health. The JIFSAN's programs support the Food Safety Modernization Act that emphasizes the concept of preventing food safety-related problems before they occur and enhance FDA's efforts to partner with other nations to improve U.S. and worldwide health.